ECMO without Anticoagulation

PROJECT SUMMARY/ABSTRACT
Life support with extracorporeal circulation through a membrane oxygenator (ECMO) is a
mainstay of advanced critical care. However, clotting in the ECMO circuit and bleeding from the
patient are the major complications, accounting for morbidity and mortality in 30% of patients.
Surface–based coatings are available, but still require systemic anticoagulation because these
surfaces do not prevent platelet adhesion and activation. We have developed a nonthrombogenic
surface which prevents platelet activation at the surface. This could eliminate the need for
systemic anticoagulation and prevent major bleeding and circuit clotting complications. The
surface is based on nitric oxide (NO), which is the mechanism of surface anticoagulation of the
normal endothelium. The chemistry, coating, NO generation, and effectiveness have been tested
in preliminary studies. This research will refine the nitric oxide surface anticoagulation system
(NOSA), and demonstrate effectiveness compared to systemic anticoagulation. The results will
apply to nonthrombogenic surfaces for other extracorporeal devices such as hemodialysis,
hemofiltration, and cardiopulmonary bypass.

Public health relevance
PROJECT NARRATIVE Extracorporeal circulation through a membrane oxygenator (ECMO) is used for severe heart and lung failure support worldwide, despite a high incidence of bleeding caused by systemic anticoagulation. Without adequate systemic anticoagulation components of the ECMO circuit are prone to clotting putting at risk patients. This research will refine our nitric oxide (NO) based nonthrombogenic surface which can eliminate systemic anticoagulation and set the stage for commercial development.